Strengthening Child Health Research Capacity in Resource Constrained Settings: Researcher Resilience Training (RRT)

PROJECT ABSTRACT
This competing renewal, “Strengthening Child Health Research Capacity in Resource Constrained Settings”
(referred to as Researcher Resilience Training, RRT) aims to advance and test state-of-the-art research methods
training and “hands-on” research experience for advanced doctoral students and early career investigators,
specifically those of African descent or focused on populations associated with the African continent, committed
to addressing the serious threats to child behavioral health (CBH), as well as prevention and care disparities in
poverty-impacted contexts. RRT develops and supports a pipeline of new CBH investigators who are prepared
to advance scientific knowledge about system and community-level structural interventions that can address the
disproportionate health burdens experienced by poverty-impacted youth of African descent via enhancing
protective family, neighborhood, system supports; reducing disparities; and advancing racial and health equity.
The RRT is guided by 4 Specific Aims: Aim 1. Recruit 5 cohorts of advanced doctoral students and early career
investigators, committed to conducting CBH prevention, intervention, services, implementation, and scale-up
research within resource-constrained settings (Fellows; n=45 across 5 years); Aim 2. Deliver a summer research
training program aimed at equipping Fellows with skills to address the challenges in resource-poor settings
through didactic instruction, mentoring, “hands-on” immersion in child- and family-focused studies, individualized
consultation, goal setting, monitoring, and ongoing support in resources over time; Aim 3. Advance
academic/community/safety net system research partnerships on CBH and child well-being; and Aim 4. Examine
the short-term and longitudinal impact of RRT (across 10 cohorts; n=90 RRT Fellows). Fellows participate in a
2-week, face-to-face training program at Washington University in St. Louis. Fellows then spend 4 to 6 weeks
embedded across a set of existing CBH-focused research studies, exclusively led by investigators of color.
Scientists with advanced methods expertise provide intensive consultation and mentoring to Fellows and are
drawn from the collaborating Center for the Study of Race, Ethnicity and Equity (CRE2) in addition to WUSTL
faculty. A rigorous mixed-methods evaluation tracks individual Fellow progress, as well as the impact of the RRT
on overall CBH research partnerships.

Public health relevance
PROJECT NARRATIVE The proposed, “Strengthening Child Health Research Capacity in Resource Constrained Settings” (referred to as Researcher Resilience Training, RRT) will deliver and test state-of-the-art methods training and “hands-on” research experience to advanced doctoral students and early career investigators, specifically those of African descent, committed to addressing the serious threats to child behavioral health (CBH) as well as prevention and care disparities in poverty-impacted local and global contexts. This short course will prepare RRT Fellows to focus their research on serious overlapping outcomes for youth living in scarce-resource communities: 1) disruptive behavioral difficulties; 2) engagement in early sexual/drug risk behaviors; and 3) early acts of delinquency, including violent behavior. RRT will develop and support a pipeline of new CBH investigators who are prepared to advance scientific knowledge about system and community-level structural interventions that can address the disproportionate health burdens experienced by poverty-impacted youth of African descent via enhancing protective family, neighborhood, system supports; reducing disparities; and advancing racial and health equity.